Form with function: Rapid phenotypic carbapenemase testing to improve detection of carbapenemase-producing organisms

PROJECT ABSTRACT
Infections due to carbapenemase-producing organisms (CPOs) are associated with high mortality rates due to
extensive antibiotic resistance, and carbapenemase genes can be transferred between bacteria leading to out-
breaks. Therefore, CPO identification has significant implications for antibiotic selection and use of infection
control practices in healthcare facilities. No antibiotic susceptibility test profile accurately identifies CPO. Yet,
existing methods for CPO detection, including phenotypic, molecular, and lateral flow assays, are not performed
by most clinical microbiology laboratories due test complexity, prolonged workflows, subjective results, reagent
instability, and high cost. Phenotypic tests have many key features necessary for a general CPO screen, yet
logistical barriers still prevent their widespread adoption. The objective of the current proposal is to evaluate the
potential impact of rapid CPO detection using a form-factor optimized phenotypic test paired with machine learn-
ing algorithms to distinguish carbapenemase gene families at the time of GNB identification. Our central hypoth-
esis is that a rapid, low-cost phenotypic test will increase CPO detection, decrease time-to-identification of a
CPO infection, and facilitate timely initiation of effective antibiotics and isolation practices. Rapid CPO detection
will be achieved with a phenotypic test optimized by our group (the mCNP) and ported into a structurally-pro-
grammed sticker microfluidic to perform four discrete reactions in a single channel (the µCNP). These assays
provide objective carbapenemase detection in ~20 minutes and will be used to achieve the objectives of this
proposal, as laid out in three aims. 1) Distinguish carbapenemase class and gene family using machine learning.
This aim is based on the capacity of machine learning to identify subtle changes over time in the colorimetric
mCNP test and provide objective, automated results to the carbapenemase class and gene-family level. 2) Eval-
uate rapid phenotypic detection of CPO in the µCNP, which will provide reproducible and stable carbapenemase
detection in a low-cost, scalable sticker microfluidic that replicates mCNP performance. And 3) Compare rapid
carbapenemase detection to standard-of-care testing by leveraging active protocols for collection of clinical cul-
tures and ongoing studies of CPO carriage and healthcare environmental contamination. Rapid CPO testing will
increase overall CPO detection and decrease time to identification from GNB-positive cultures and surveillance
rectal swabs. Expected results include the demonstration of the utility of the µCNP as an accessible phenotypic
carbapenemase test for appropriate antibiotic selection and rapid identification of CPO-colonized individuals for
timely contact isolation. We envisage an important positive impact as our platform will provide equitable access
to carbapenemase testing, improve patient outcomes, and prevent CPO outbreaks in healthcare networks.

Public health relevance
PROJECT NARRATIVE Identification of carbapenemase-producing organisms can improve outcomes from infections with these highly antibiotic-resistant organisms and inform outbreak prevention strategies for healthcare facilities, but existing methods for detection have significant limitations that prevent widespread adoption. The objective of this pro- posal is to evaluate the impact of rapid, low-cost, and simple detection of carbapenemase-producing organisms with a form-factor optimized test to increase detection, decrease time-to-identification of a carbapenemase-pro- ducing organism infection, and facilitate timely initiation of effective antibiotics and isolation practices. Expected results include the development of a low-cost, optimized device that is easy to perform and will augment existing laboratory and surveillance workflows to inform appropriate antibiotic selection and the judicious use of contact isolation.